ANDROGENS AND SLEEP APNEA-- AIRWAY ANATOMY AND FUNCTION

The broad goals of this project are: 1. To determine the role that androgens play in the structure of the pharyngeal airway in men. 2. To determine the role androgens play in the physiologic control of airway patency in men. 3. To determine the effects of excess androgens on sleep disordered breathing in women.